Discovering Our Story, to develop the Chemawa Journey of Transformation

Substance use and sexual health risk are increasingly prevalent, costly, and deadly -- fueling a synergistic
epidemic in the United States (US) that disproportionately affects American Indian and Alaska Native (AIAN)
communities. AIAN youth are at the heart of the AIAN health crisis. AIAN youth are
disproportionately affected by many of these historical, structural, social, and behavioral factors that contribute
to significant health disparities including high alcohol, tobacco, opiate and other drug (ATOD) use and sexual
and reproductive health risks (SRH; ATOD-SHR). The overall mean age of tobacco use, alcohol use, and
marijuana initiation for AIANs is much younger (11.5 years) than the general population, with AIAN youth
having the highest prevalence of smoking and the earliest age of first use of ATOD. Alarmingly, more that 20%
of Native high school students who used a prescription pain med without a prescription also used heroin in the
past 30 days. Substance use is one of the most significant risk factors for unprotected sex and AIAN youth have
the earliest age of first sexual intercourse. AIANs under 25 years of age have three times the rate of chlamydia,
gonorrhea, and syphilis compared to White youth. Taken together, these ATOD-SHR disparities underscore
the urgent need for interventions that simultaneously target ATOD and SHR among AI teens. While there is a
paucity of research addressing the ATOD-SRH prevention needs of AIAN youth in general, there is even less
information available on ATOD-SRH-related disparities for the nearly 1 out of 10 AIAN youth attending the 183
tribal day or boarding schools nationwide. To address this crisis and the dearth of evidence-based programs for
this population, the proposed study, prepared in response to PAR-17-496, involves a 5-year RO1 to test the
preliminary efficacy of the Chemawa Journey of Transformation–Native Youth Health Leadership Program
(CHJ) which is an adapted and expanded version of the Discovering Our Story intervention, a 2010 SAMSHA-
identified best practice AIAN strengths-based comprehensive substance use and health risk prevention and
health leadership program for AIAN youth. The CJOT emphasizes a holistic, positive youth approach that
incorporates storytelling with traditional archetypes and responsibilities as both a process and metaphor for
guiding AIAN youth through behavioral change. The CJOT is a culturally-centered experiential 8-week (10
sessions) school-based positive youth health leadership development intervention to prevent ATOD use and
SHR among AIAN youth (ages 13-16). The program involves a 2-month intervention (3 individual sessions + 10
sessions) + 5 booster sessions including digital storytelling training + 1 community event (digital and oral
storytelling premiere) that targets behavior change relative storytelling and a youth-led storytelling event.

Public health relevance
Project Narrative To stem the epidemics of substance abuse and sexual risk factors related to health disparities among American Indian and Alaska Native (AIAN) youth, this collaborative partnership between a Native school, an AIAN organization, and a university team of Native researchers will focus on the development of sustainable health practices and youth leadership development. Targeting at-risk AIAN youth for primary prevention efforts and enlisting them to become positive youth development health leaders may stimulate important individual and community-wide changes. Better information is needed on cost-effective and culturally-grounded methods to prevent substance use as well as sexual risk reduction results among AIAN youth so that current and future generations of Native communities can thrive and live healthfully.